Evaluation of Clinical Outcome Assessment (COA) and Potential Biomarkers to Facilitate Interventional Trial for Mucopolysaccharidosis IIID Patients

Project Summary
Sanfilippo disease (mucopolysaccharidosis type III; MPS III) is a devastating neurodegenerative lysosomal
storage disorder of childhood whose pathologic features are neurologic: slowing of development, severe
behavioral problems, progressive cognitive decline, dementia, and decline in motor skills leading to immobility,
unresponsiveness, and death. We have focused on MPS IIID caused by a deficiency of alpha-N-
acetylglucosamine-6-sulfatase (GNS). Because MPS IIID is rare (1 in a million) and affects the brain (which is
difficult to treat) no cure or treatment is available and there are at least five patients in the USA to our knowledge.
Sanfilippo patient organizations have 19 additional cases registered around the world (see letter of support). Dr.
Patricia Dickson and Dr. Tsui-Fen Chou (LABioMed) have developed an enzyme replacement treatment (ERT)
for MPS IIID. Our strategy proposes to deliver recombinant human alpha-N-acetylglucosamine-6-sulfatase
(rhGNS) via intracerebroventricular infusion to effectively treat the underlying causes of the neurologic symptoms
that dominate MPS III pathology. ERTs can have a dramatic effect on the quality of life and patient development
especially when administered early in developments. There are several examples of successfully
commercialized ERT’s (e.g. laronidase (MPS I), idursulfase (MPS II), etc.) and BioMarin recently received
approval for an ERT for a form of Batten disease, CLN2. Other ERTs for MPS I, II, and IIIB are in Phase I trials.
Both the FDA and investors are familiar with ERT and its commercialization path, which will greatly increase the
chances of reaching a clinical trial. LABioMed has filed a US patent on rhGNS and Phoenix Nest, Inc. has
licensed it. Our pivotal nonclinical and manufacturing plans are on track.
We had a positive interaction with the FDA and got guidance for moving our program into the clinics. In
preparation for the interventional study the recommendation was for a thorough natural history study (NHS) in
the available patient population with a broad net to capture endpoints that are most likely to predict the clinical
benefits in each individual. Since the number of diagnosed patients is small the collected data form each
individual would be their own control at the time of intervention, where the patient will receive the recombinant
enzyme. Most of the work will be executed by contracted service providers. The clinical trial itself will be
conducted at Columbia University under the guidance of Dr. Chung. She has experience with over 10 clinical
trials interventional and observational. The clinical protocol was designed by the team at Phoenix Nest with help
of KOLs and clinical experts in the MPS III field. We have engaged expert third party clinical service providers to
help with the execution, monitoring and data collection. Crucial data collected from the patients on this study will
help us develop clinical outcomes that will be tools for measuring the efficacy of our rhGNS therapy and will be
primary endpoints on the pivotal study. The success on this trial will put a step closer to executing the pivotal
trial to assess the efficacy of our experimental therapy and its commercialization.

Public health relevance
Project Narrative Our enzyme replacement therapy program has achieved goals set on Phase I STTR, Phase II SBIR and continuing to make strides towards achieving our goals for Phase II SBIR. To support IND filing and initiation of the interventional clinical trial we need this CRP grant to support execution of this trial for identification of critical measurable clinical outcome and potential biomarkers. These data will ultimately support commercialization the first therapy for MPS IIID.